Applying Genomics and Omics in Pig to Human Decedent Xenotransplantation

PROJECT SUMMARY – OVERALL
Xenotransplantation has the potential to provide nearly unlimited organs for transplantation. Extension of
xenograft survival in nonhuman primates (NHP) and xenotransplants to living and brain-dead humans have
advanced the field toward clinical trials. Despite these advances, xenograft survival in the few clinical cases
performed to date have been limited by infectious complications (of both host and donor origin) and by the
development of cellular and antibody-mediated rejection. The development of sensitive assays to detect host
and donor microbes, coupled with platforms to guide clinical responses, and assays to detect early markers of
xenograft rejection would improve outcomes of clinical xenotransplants. At NYU Langone, we developed an
innovative decedent model to study the results of xenografts transplanted to humans and gain experience in a
fail-safe environment that also enables frequent sampling of recipient blood and tissues. We have now
performed three kidney and two heart xenotransplants in the decedent model, along with one clinical kidney
xenotransplant. We have performed innovative multi-omic analyses of the recipients of these transplants.
Our preliminary data show that we can detect both host and donor-derived microbes in decedents with an
unbiased approach, and that we can detect donor-derived cell-free DNA in recipients at the time of biopsy-
proven rejection episodes. We now plan to biobank specimens from 21 additional decedents and perform
multi-omic analyses of these recipients. Our program consists of two projects: Project 1 develop sensitive
assays to detect host- and donor-derived microbes post-transplant and develop platforms that guide effective
clinical management of infections in xenograft recipients; Project 2 will develop assays to detect donor-derived
cell-free DNA in recipient blood. We will expand these studies by developing a methylation atlas of pig cells
that will enable us to identify the cell of origin of any donor-derived cell-free DNA we detect. The projects will
be supported by two Cores: The Molecular Science core contains biobanked specimens from the 5
decedents we have performed to date. We will biobank specimens from the additional 21 decedents and then
perform multi-omic analyses of these samples. The Core will also support data analysis of these results. The
Administrative Core will provide administrative oversight, coordinate internal scientific meetings, organize
travel to consortia meetings, and ensure each Project is meeting their defined milestones. Collectively, these
projects will provide a new level of understanding of the management of xenograft recipients and the human
immune response to xenografts. Upon successful completion of the proposed research, we expect to
develop platforms that improve the clinical management of patients who enroll in the first clinical trials of
xenotransplantation, with the long-term goal of developing xenotransplantation into a standard clinical
treatment option for organ failure.

Public health relevance
Overall Project Narrative Our overarching aim is to use multi-omics profiling, which spans genomics, transcriptomics, proteomics and metabolomics profiling of biospecimens collected at prospective timepoints from 25 new and 6 existing pig-to- human decedent xenotransplantation studies performed in NYU, for discovery and validation of prognostic and diagnostic biomarkers of post-transplant complications. We will focus heavily on Infection discovery and surveillance using different metagenomic and other sequencing approaches (Project 1) and Rejection related biomarkers using cell-free DNA and other approaches (Project 2).